Restoration of Structure and Function in the Diabetic Cornea

Project Summary/Abstract
Objective/Hypothesis. Diabetes is expected to reach epidemic levels by 2030. Despite the prevalence of diabetic
retinopathy, many adult diabetic patients develop visually disruptive corneal complications, including impaired
wound healing and corneal neuropathy. Unfortunately, treatment for diabetes-induced damage to the cornea remains
severely limited to strict glycemic control. Our objective is to investigate a promising peptide-based combination
therapy that effectively targets hyperglycemia-responsive circuits in the cornea. By doing so, we hypothesize that
Tβ4/VIP combination treatment can prevent high glucose-induced damage to corneal structure and function. In
addition, we examine one such responsive circuit – the DDR-TRP axis – a novel pathway that has yet to be explored
in the cornea.
Specific Aims. This proposal intends to: 1) establish the therapeutic role of Tβ4 and VIP as a combination treatment
against diabetes-induced corneal complications; and 2) elucidate the DDR-TRP axis under hyperglycemic conditions.
Study Design. Our experimental approach is designed to include both in vitro and in vivo cell-specific analyses. In
vitro assessments are focused on corneal epithelial cells and stromal fibroblasts complemented by extensive,
comprehensive in vivo assessments that include morphological changes to the epithelium, stroma, epithelial-stromal
interface, endothelium, changes in corneal nerves and tear film, AS-OCT, endothelial cell density measurements,
fibroblast differentiation, and phenotypic profiling to distinguish between keratocytes, fibroblasts, myofibroblasts,
immature/mature dendritic cells, monocytes/macrophages, and neutrophils. In vivo studies include the use of two (2)
type 1 diabetic mouse models (STZ-induced and spontaneous Akita) to account for any potential effects due to STZ
exposure and will assess changes in corneal structure and function, including corneal integrity and barrier function,
sensitivity and innervation, inflammation, and wound healing; all of which not only focus on improved disease
outcome but mechanistically examine the role of the DDR-TRP axis and how Tβ4/VIP therapeutically regulates this
axis.
Impact. Overall, the studies proposed seek to delineate a newly identified mechanism of diabetes-induced damage
while providing key preclinical evidence for the development of a novel therapeutic approach with robust
translational relevance and potential for significant impact on diabetic corneas.

Public health relevance
Project Narrative Diabetes is the leading cause of adult-onset blindness with majority of patients presenting with some level of diabetes- induced corneal complications. Yet there remains a significant lack of available treatments. The current proposal not only markedly advances our understanding of disease pathogenesis, but provides pre-clinical data supporting the development of promising, novel therapy for human treatment of this visually disruptive condition.